Meeting support for Cancer MoonshotTM Symposium on Personal Control of Genomic Data for Research.

Support to the NCI by Scientific Consulting Group. Meeting support for Cancer MoonshotTM Symposium on Personal Control of Genomic Data for Research.